Circuit dynamics of predictive vocal suppression in auditory cortex

Project summary
During vocalization, the nervous system must dissociate vocal feedback from other sounds. To make this
distinction, vocal motor-related signals are harnessed to selectively suppress responses of auditory neurons to
predictable acoustic features of vocal feedback. This predictive suppression enhances the detection of sounds
that occur simultaneously with vocal feedback and also facilitates the detection of vocal errors, a process
important to vocal learning. In contrast, dysfunctional suppression is thought to give rise to auditory
hallucinations in disorders like schizophrenia. The prominence of predictive vocal suppression in the auditory
cortex has been most thoroughly demonstrated with noninvasive recordings in speaking humans and
extracellular recordings from pyramidal neurons in vocalizing monkeys. However, the cellular determinants of
predictive vocal suppression are unknown because the auditory cortex of monkeys and humans is not readily
amenable to advanced genetic methods useful for circuit interrogation. While our group previously found that
mouse auditory cortex was suppressed during vocalization, these recordings were conducted during courtship,
a state that also features locomotion, arousal, and olfactory stimulation, all of which broadly suppress
pyramidal neuron activity. I have developed a novel social interaction paradigm in which I can monitor
vocalizations, locomotion, and arousal while conducting multiphoton imaging the activity of pyramidal neurons
and interneurons in the mouse auditory cortex. I have combined this paradigm with sound presentations to test
the excitability of auditory cortical neurons during vocal and non-vocal social interactions. In Aim 1, I will use
this approach to measure suppression related to vocalization, locomotion, and arousal during social
interactions to test the hypothesis that vocalization corresponds with specific suppression of pyramidal neurons
that respond to vocal feedback and activation of certain interneurons, while non-vocal facets of courtship
suppress a broader population of neurons. In Aim 2.1, I will image from the auditory cortex while systematically
distorting vocal feedback with air enriched with gradations of helium to test the hypothesis that vocal
suppression is predictive of vocal feedback. In Aim 2.2, I will test the hypothesis that vocal suppression relies
on strong activation of interneurons by vocal motor-related signals by imaging from the auditory cortex of
vocalizing, congenitally deaf mice. These experiments will test the specificity and predictive power of vocal
suppression in the mouse auditory cortex while providing cellular resolution of its underlying mechanisms.
Given the similar organization of the human and mouse auditory cortex, my findings will shed light on cortical
circuits that influence vocal perception during human speech and whose dysfunction interferes with
communication and well-being.

Public health relevance
Project Narrative Our ability to distinguish our own vocal sounds (vocal feedback) from other sounds is essential to communication and hearing during speech. Vocal motor-related signals that suppress auditory responses to predictable vocal feedback are thought to underlie this ability, but the neural mechanisms mediating this suppression are unknown. This proposal combines the advanced genetic and physiological toolkit in the mouse with an innovative method to distort vocal feedback to elucidate these neural mechanisms.